Metabolic crosstalk through vascular endothelium-secreted factors

Abstract
The metabolic disorders of obesity and type 2 diabetes mellitus (T2DM) impact one in three adults. The
inability of insulin to suppress hepatic glucose production and promote glucose uptake into peripheral tissues is
a hallmark of T2DM. However, the underlying mechanism of liver insulin resistance remains incompletely
understood. This gap in knowledge is an important problem because it hinders the development of targeted
metabolic therapies to manage the growing clinical burden of T2DM.
The vascular endothelium coordinates the delivery of endocrine hormones and small molecules to target
tissues. Yet, how specific endothelial factors exert impacts in metabolic tissues remains undefined. Bone
morphogenetic protein (BMP)-binding endothelial regulator (BMPER), highly secreted from vascular
endothelium, adapts endothelial cells (ECs) to inflammatory and nutrient stress in diverse organ
microenvironments. In new studies, we observed inducible knockout of BMPER (iKO) globally or specifically in
endothelium caused hyperinsulinemia, glucose intolerance and insulin resistance independently from obesity
and inflammation. These results suggest the vascular endothelium secretes BMPER to maintain glucose
homeostasis. Subsequent experiments demonstrated adeno-associated viral BMPER delivery dramatically
alleviated diabetes in mice. In humans, BMPER plasma levels are reduced in insulin resistant subjects
compared to normoglycemic subjects, supporting an important role for BMPER in defending insulin sensitivity.
Mechanistically, we observed BMPER transactivated the insulin signaling pathway in metabolic tissues.
Therefore, we hypothesize that BMPER endocytosis promotes insulin sensitivity. To test this hypothesis, we
propose the following aims: 1) determine the metabolic consequences of BMPER depletion; 2) establish the
anti-diabetic potential of recombinant BMPER; and 3) define the mechanisms that govern BMPER regulation of
insulin action. Collectively, these studies suggest an uncharacterized pathway that may define new therapies
to minimize the long-term clinical burden of T2DM.

Public health relevance
The prevalence of type 2 diabetes mellitus and insulin resistance has rapidly increased over the last several decades. Individuals with type 2 diabetes mellitus, constituting about 90% of all cases of diabetes, are unable to properly use their insulin supply due to insulin resistance. We will elucidate regulatory mechanisms and suggest new and unexpected therapeutic targets and strategies against metabolic syndromes, type 2 diabetes mellitus, dyslipidemia, insulin resistance, NPC disease, nonalcoholic fatty liver disease and other metabolic disorders.